Computational Imaging of Renal Structures for Diagnosing DiabeticNephropathy

Project Summary
At the current rate, one in three U.S. adults will be diabetic by 2050. A disease secondary to diabetes is diabetic
nephropathy (DN), which causes end-stage renal disease (ESRD) for >225K U.S. patients (50% of all ESRD
cases), accounting for >$19K in yearly Medicare costs for each patient. Measurement of minute urinary albumin
(microalbuminuria) is the most common non-invasive clinical biomarker of DN. In order to conclusively define
DN severity, pathologists conduct qualitative manual estimation of glomerular structural damage in renal
biopsies. However, renal glomerular structure in DN biopsies does not often correlate with less invasive clinical
biometrics (e.g., estimated glomerular filtration rate, urine protein, serum creatinine and glucose levels). This
traditional diagnostic method is approximate, subjected to user bias, time-consuming, and has low diagnostic
precision in early disease stages; further, manual hand identified features may not always accurately predict
disease progression. Computational image analysis offers the opportunity to project clinical biometrics onto
glomerular histological structures. This method provides finer precision in identifying structural changes that lead
to physiological changes, which in turn reduces the required clinical resources and time for diagnosis, and
provides clinicians with greater feedback to improve early intervention. We have developed computational tools
to quantify renal structures in human DN biopsies. Our tools quantify glomerular features in histological renal
tissue images more efficiently than manual methods. We have also derived a quantitative progression risk score
(PRS) describing DN progression risk estimated off only a single biopsy point. Here, we will rigorously analyze
the performance of these methods to predict disease progression using histological images of human DN renal
biopsies. We will computationally quantify morphologically diverse DN-indicative intra-glomerular features. We
will analytically integrate computationally derived glomerular features with clinical biometrics in order to develop
patient-specific PRS to identify patients at risk of renal failure. Since human renal DN data is sparse, we will also
use murine data, which can be generated in large amounts in a controlled fashion, to initially train the
computational models. We will then refine the model for clinical use by fine-tuning the parameters using human
data. The innovation is in the novel integration of traditional clinical detection methods with traditional diagnostic
methods, under a computational schema for enhanced precision. This integration will lead to computational
disease predicting biomarkers of the earliest measurable renal DN dysfunction. We will study the predictive
power of these markers to foretell future clinical endpoints from earlier time points. These methods support the
development of quantifiable prognostic and predictive information, which is dynamic over the disease course,
easily discriminated, and is highly informative for modeling disease progression or response to therapy. This
study will 1) enable earlier clinical predictions, thus extending windows for interventions of evolving DN; and 2)
work as a pilot platform for future studies to computationally derive renal biomarkers predictive of other diseases.

Public health relevance
Narrative Diabetic nephropathy (DN) causes end-stage renal disease (ESRD) for >225K U.S. patients (50% of all ESRD cases), accounting for >$19K in yearly Medicare costs per patient. Renal glomerular structure in DN biopsies, however, does not often correlate with less invasive clinical biometrics (e.g., estimated glomerular filtration rate, urine protein, and serum creatinine and glucose levels). Our research will transform diagnostic methods and treatment of DN by combining traditional clinical detection methods with traditional diagnostic methods under a computational schema to precisely identify the earliest measurable glomerular structural changes, as well as identify patients at risk of renal failure, thus opening new windows to precision therapy.